Association of LOY with Other Forms of Genome Instability

Summary/Abstract
Loss of the Y chromosome (LOY) in hematopoietic cells is a prevalent age-related phenomenon with
significant health implications, including increased risks of cancer, neurodegeneration, cardiovascular
diseases, and overall mortality. While recent genomic studies have linked LOY to disease risk, the
mechanistic connections, particularly in the context of aging, remain unclear.
Emerging evidence from cancer research suggests that LOY may contribute to genomic instability,
potentially due to defects in DNA repair mechanisms and cell cycle regulation in Y-chromosome-lacking tumor
cells. This area of research in aging is relatively unexplored and warrants further investigation.
Leveraging the unique aging biobank at the Albert Einstein College of Medicine, where we have
determined LOY status, this study aims to rigorously examine the causal relationship between LOY and
genomic instability using cutting-edge genomic and molecular techniques.
We hypothesize that LOY is associated with increased genome instability, possibly through elevated
somatic mutation rates, chromosomal aberrations, or shared genetic determinants. Our study comprises two
aims: Aim 1 will assess whether aging men with high LOY exhibit a higher burden of other types of mutations.
Using the Einstein Longevity Cohort, we will apply advanced methodologies, including single-molecule and
single-cell studies, to evaluate genomic instability in 40 individuals with varying LOY status. In aim 2 we will
induce LOY and study its effect on genome stability using induced pluripotent stem cells (hiPSCs)
differentiated into T cells.
By elucidating the mechanistic basis of the correlation between LOY and genomic instability, this
project may offer insights relevant to similar phenomena in women, such as the genetic determinants of
aneuploidy or LOX, which have also been reported in aging women. This understanding could facilitate the
exploration of molecular pathways, identification of biomarkers, and development of targeted interventions.
Ultimately, this novel research may lead to personalized medical approaches and improved health outcomes,
particularly in the context of healthy aging.

Public health relevance
Project Narrative This research investigates how the loss of the Y chromosome (LOY) contributes to genomic instability, a fundamental process underlying many age-related diseases such as cancer, cardiovascular diseases, and neurodegenerative disorders. Understanding these mechanisms could lead to new insights and interventions for improving health in aging populations.